Exploring the consequences of differential immune investment on molecular aging phenotypes in subsistence-level populations

PROJECT SUMMARY
Worldwide, the number of adults over the age of 60 will double to 2.1 billion by 2050, leading to an
enormous rise of age-related, non-communicable diseases (NCDs) such as dementia, type 2 diabetes, and
cardiovascular diseases. Previous work with small-scale, subsistence-level groups suggests that these
“diseases of aging” may be avoidable and not an inevitable part of getting older. For example, age-matched
samples of Tsimane forager-horticulturalists in Bolivia exhibit the lowest levels of coronary artery disease in the
world and slower brain atrophy than Americans and Europeans. The ability of subsistence-level groups to
“escape” age-related diseases has been hypothesized to be partially driven by differential immune investment
across the life course: these groups are highly physically active, often resource constrained, and constantly
exposed to immune threats–all factors which are predicted to keep the runaway sterile inflammation associated
with many NCDs in check. However, no study to date has used modern ‘omics tools to understand age effects
on immune investment in subsistence-level contexts, or how lifestyle change may directly alter these patterns.
The central objective of this study is to use a multi-omic approach to understand the effect of lifestyle on
immune activity across aging. Using within and between-population comparisons, I will test how immunological
aging varies between individuals experiencing diverse lifestyles, ranging from traditional subsistence-level to
highly urban lifestyles. To do so, I will work with the Tsimane of Bolivia, the Turkana of Kenya, the Orang Asli of
Malaysia, and with public data generated from US individuals. I will focus on three molecular phenotypes from
peripheral blood that are known to be age-associated in post-industrial contexts–gene expression, DNA
methylation (DNAm), and clonal hematopoiesis of indeterminate potential (CHIP)–and I will characterize these
features in subsistence-level Tsimane, Turkana, and Orang Asli. I will then explicitly ask how lifestyle variation
impacts patterns of aging and immune function using (i) cross-population comparisons between these
subsistence-level groups and a highly urbanized population (i.e., the US) and (ii) within-population comparisons,
as subsets of the Turkana and Orang Asli have recently moved to urban city centers while others still practice
their traditional pastoralist (Turkana) or hunter-gatherer (Orang Asli) lifestyles. I predict that the energy excess
characteristic of sedentary, calorie dense urban lifestyles will be associated with age-related changes in
somatic mutation rates as well as inflammatory DNAm and gene expression, while in subsistence-level
settings immune variation will primarily track pathogen responses with blunted age effects. Importantly,
I will assess these predictions using both within- and between-population comparisons to reveal robust,
generalizable results. Together, this study will illuminate how urbanization impacts immunological aging typical
of NCDs and will generate extensive ‘omics and health knowledge for historically marginalized groups that are
chronically under-represented in genomic studies.

Public health relevance
PROJECT NARRATIVE Many non-communicable, inflammation-based diseases of aging in Western, urbanized countries are observed at low frequencies in subsistence-level societies, suggesting that these outcomes are not an inevitable part of the natural aging process and may be due to differences in immune activity across lifestyles. This project seeks to understand the biological mechanisms underlying these observations by quantifying the effects of urbanization on peripheral immune system gene expression, DNA methylation, and somatic mutations (clonal hematopoiesis of indeterminate potential) (i) within subsistence-level populations in which individuals are moving to urban city centers, and (ii) between three subsistence-level societies and the US, a highly urban country. The results of this work will contribute to our understanding of how urbanization impacts immune gene regulation and risk of inflammation-based diseases of aging across diverse populations.